National Institute on Drug Abuse Clinical Trial Network: New England Consortium Node

ABSTRACT
This study will (1) recruit, train and provide resources to approximately 30 Emergency Department (ED) sites
throughout the U.S. using implementation facilitation strategies to provide ED-initiated BUP for patients
presenting with opioid use disorder (OUD) not receiving medications for opioid use disorder (MOUD). Once
implementation is adequately achieved, the sites will (2) conduct a randomized controlled trial (RCT) to
compare the effectiveness of sublingual buprenorphine (SL-BUP) versus extended-release buprenorphine
(XR-BUP) on ED patients' engagement in formal addiction treatment 7-days after their ED visit. In addition, in
an ancillary component of the study, we will (3) assess the use of XR-BUP in ED patients with Clinical Opioid
Withdrawal Scale (COS) scores < 8 in a case series to potentially expand the eligibility of patients in the larger
RCT to those presenting with little to no opioid withdrawal symptoms. Finally, we will (4) develop and validate
ED electronic health record (HER) opioid-related phenotypes, both of which will inform the main RCT.

Public health relevance
NARRATIVE This project is designed to compare the effectiveness of XR-BUP and SL-BUP induction in approximately 2000 patients with OUD not receiving MOUD in the ED on the primary outcome of engagement in formal addiction treatment at 7 days.